Leptin and Insulin Signaling in SF1 Neurons and Energy Homeostasis

Abstract
The endocannabinoid system, consisting of the CB1R and lipid derived endogenous cannabinoid molecules,
has been shown to significantly contribute to the development of diabetes and obesity. Although CB1R inverse
agonists are effective at improving insulin sensitivity and protecting against diet induced obesity, these drugs
have severe side effects associated with the widespread distribution of CB1Rs in the CNS and the periphery.
The goal of this application is to investigate the role of CB1Rs in the SF1 neurons of the ventromedial
hypothalamus to regulate energy homeostasis. We will also examine if this subset of neurons is responsible for
the metabolic improvements associated with CB1R inverse agonists. We anticipate the results from our
investigation will provide novel insight to the development of effective therapies to combat metabolic disease
while circumventing potential side effects.

Public health relevance
Project Narrative The endogenous cannabinoid system is a key regulator of whole body energy balance. Activation of this system contributes to the development of diabetes and obesity, whereas drugs that block the cannabinoid system can protect from diabetes and obesity. While effective, these drugs also have severe side effects. We believe that the cannabinoid system in a small subset of neurons regulates energy and glucose balance. Studying these neurons will aid in the development of novel therapies, without side effects, to better treat or prevent diabetes and obesity